Training in Translational Science and Cardiovascular Research

ABSTRACT
This proposal seeks support for a well-established training program in translational cardiovascular research for
MD and PhD postdoctoral fellows at Oregon Health & Science University (OHSU). The training program has
a long history of training excellence and is an essential component of the educational and training activities of
The Knight Cardiovascular Institute. Over the past decade, the program has trained many fellows, who have
been successful in obtaining independent positions in academics. Our trainees included equal numbers of men
and women and MDs and PhDs, and included fellows from under-represented minority groups. We request
funding for 6 post-doctoral fellows per year (3 positions for two years each). The program offers exciting
opportunities for bench to bedside, multidisciplinary training in one of three established Training Hubs that
specialize in: 1) Cardiovascular Regulation, which includes physiological regulation, ischemia-reperfusion and
hypertension, 2) Cardiovascular Inflammation, which includes atherosclerosis, diabetes, thrombosis, and viral
infections with relevance to cardiovascular disease (including COVID-19), and 3) Cardiovascular
Development, which includes cardiovascular genetics, genomics and fetal programming. The faculty mentors
are highly recognized and funded scientists who have a strong track record of training postdoctoral fellows. The
program is highly interdisciplinary and mentors' expertise cover a wide range of the translational spectrum.
Laboratory research is supplemented by course work, seminars, journal club, and meetings within a specific
science group. Course work includes research design, biostatistics, cardiovascular physiology and genetics. All
trainees participate in responsible conduct of research training, scientific writing, entrepreneurship and team
science and leadership training. This program is unique at OHSU in that mentoring is carried out by a
multidisciplinary team, and because training is specifically designed to translate basic cardiovascular research
into clinical benefit. The primary mentor will be assisted by at least two co-mentors, who complement the primary
mentor's expertise by bringing clinical, basic science or technical expertise. The training outcome will be
scientists with a broad outlook and a focus on bringing science to the bedside. The application includes a strong
recruitment plan for underserved minority trainees and an evaluation process. A Program Advisory Committee
monitors the progress of every trainee as they meet specific mileposts in preparation for a research career. In
summary, the proposed cardiovascular research training program will provide a unique opportunity for
multidisciplinary training, and successful trainees will be well equipped to initiate independent research careers
in translational cardiovascular research.

Public health relevance
Project Narrative This is a research training program for postdoctoral fellows at Oregon Health & Science University, Portland, Oregon. The proposed program will address an urgent need for cardiovascular scientists who are trained broadly in translational sciences focused on cardiovascular disease. The program will train 30 scientists who will join the ranks of academia and promote cutting-edge research in heart disease.